Air Pollution, Environmental Injustice and Progressive Pulmonary Fibrosis

Project Summary
Air Pollution, Environmental Injustice and Progressive Pulmonary Fibrosis
Progressive pulmonary fibrosis (PPF) is a severe, fatal complication of interstitial lung disease (ILD). For
patients who develop PPF, mortality is high and treatment options are limited. The cause of PPF is unknown.
Research suggests that exposure to components of air pollution, including fine particulate matter (PM2.5) and
nitrogen dioxide (NO2) is associated with an increased incidence of idiopathic pulmonary fibrosis- a subtype of
ILD similarly characterized by rapid fibrotic progression. However, whether exposure to air pollution leads to a
similar increase in the risk for PPF has not been studied. As a result of environmental injustice, individuals
living in neighborhoods with a high social vulnerability index face a disproportionate exposure to ambient air
pollution. Because of this, residents in these neighborhoods may have an increased risk of PPF.
Dr. MacMurdo is a specialist in occupational and environmental interstitial lung disease at the Cleveland Clinic.
Her research aims to combine patient centered geospatial mapping techniques with advanced modeling
approaches to better understand the interaction between individual, exposure, and environment. Through this
proposal she aims to leverage a unique, previously developed cohort of patients with ILD to investigate: (Aim 1):
The relative and combined impact of air pollution exposure and social vulnerability on the incidence of PPF in
patients with ILD, and (Aim 2) The exposure to occupational and indoor air pollution experienced by patients
with ILD who develop PPF, and how health behaviors and neighborhood level factors may impact this
exposure.
This award will provide an outstanding training vehicle for Dr. MacMurdo’s development into an independent,
NIH funded patient-oriented researcher, poised for leadership in investigations at the intersection of air
pollution, environmental injustice, and respiratory health. It will also identify mechanisms to improve health
outcomes for patients with ILD. Quantifying the impact of ambient air pollution exposure on the risk of PPF will
provide evidence to support interventions to reduce individual exposure to ambient air pollution in patients with
ILD. Identifying neighborhood factors associated with an increased risk of PPF will guide work to develop
mechanisms to increase access to specialist ILD care.

Public health relevance
Project Narrative While 20% of patients with interstitial lung disease will develop progressive pulmonary fibrosis, the risk factors that lead to this severe, fatal complication are unknown. This project aims to investigate how neighborhood level factors may impact the risk of developing progressive pulmonary fibrosis, with a focus on exposure to outdoor air pollution. By identifying the role that air pollution plays on the risk of progressive pulmonary fibrosis, we can increase early recognition of this condition in communities who face high levels of air pollution exposure, and work to find ways to help patients with ILD reduce their exposure to air pollution.